Wearable Multi-modality Cuffless Blood Pressure Monitoring

Alzheimer’s disease (AD) is typically diagnosed by markers of amyloid-beta (ABeta) deposits in the brain,
cerebrospinal fluid, and/or blood. So far, such hallmarks have proven insufficient for explaining the
development of AD, and identifying at-risk individuals. A growing body of evidence suggests that ABeta is cleared
via the glymphatic system, which is especially active during sleep, and it is now also thought that glymphatic
function is driven by vascular pulsations. This is intriguing given the reliable findings of both vascular
dysfunction and disordered sleep in AD patients, and together these observations suggest potential causal
links between cerebrovascular status, sleep disruption, and AD progression. Indeed, reduced cerebrovascular
pulsatility and changes in the blood pressure (BP) pulse wave have already shown to be related to AD severity.
Currently, there is no technology suitable for long-duration (e.g. 24-hr) beat-to-beat characterization of these
vascular and glymphatic dynamics in AD. If such monitoring was possible, this could help researchers
investigate several extant hypotheses regarding the underlying mechanisms of AD, that ultimately could help to
improve AD detection and treatment strategies.
Our team at Massachusetts General Hospital has developed a wearable, multimodal cerebrovascular
monitoring platform, called NINscan, which is capable of up to 24-hr use. This technology is being enhanced in
our active R01 project (EB027122), using our novel superficial temporal artery tonometry (STAT) method for
continuous, cuffless BP monitoring at the level of the head. This supplement proposes two specific aims. In
Aim 1 we will further develop NINscan for multimodal cerebral vascular and fluid monitoring, as well as
optimizing its use for ambulatory monitoring in AD. This will be accomplished by improving chromophore and
depth sensitivity as well as patient usability. For Aim 2, we will conduct feasibility testing in older adults and AD
patients, both in the lab and during 24-hr recordings (including daily activities and sleep). This data will allow us
to conduct preliminary comparisons between healthy and patient groups on (i) BP, (ii) BP pulsatility, (iii)
cerebral blood and water (glymphatic) volumes, and (iv) blood and water volume pulsatility. The data will also
be added to the Physionet database being developed as part of EB027122.
This supplement will lead to the most comprehensive cerebral monitoring system capable of 24-hr use,
including static and dynamic BP and cerebral fluid measurements that appear key to AD. We expect that this
enhanced capability will facilitate a better understanding of AD and hopefully stimulate the development of new
diagnostics or therapies, as well as providing capabilities that are useful well beyond AD.

Public health relevance
Project Narrative Recent evidence suggests that cerebrovascular parameters—including blood pressure (BP) and vascular pulsatility—may play a key role in the clearance of amyloid-b from the brains of patients with Alzheimer’s Disease (AD). However, technologies to monitor these variables continuously, beat-to-beat, over long time periods (including during both wake and sleep) have been lacking. In this supplement, we will leverage the cerebrovascular monitoring and BP technologies from the parent R01, enhance them with more comprehensive sensitivity to cerebral fluids and for up to 24-hr use with AD patients, and then conduct feasibility tests to provide a technology that can improve our understanding of the links between vascular dysfunction and AD development, and ultimately lead to new diagnostic and therapeutic tools for AD.